Prenatal diet-stress interactions and the maternal metabolic response in human pregnancy

ABSTRACT
RESEARCH SUMMARY: Maternal glucose-insulin homeostasis in pregnancy represents one of the
most important physiological processes for maternal and child health outcomes. Although
maternal diet is a key regulator of this process, its effects vary widely across
individuals, suggesting other moderating factors may be at play. Based on studies that demonstrate
diet and stress interact at various biological and behavioral levels, and the biological response
to stress alters glucose-insulin homeostasis, I submit that stress likely represents a
moderator of considerable significance in pregnancy. Yet, existing studies of pregnancy
have not considered their combined effects. The primary goal of this K99/R00 project is
to test the hypothesis that maternal prenatal stress may exacerbate the unfavorable
effects of unhealthy diet on gestational glucose-insulin homeostasis. I aim to address
this knowledge gap using two complementary approaches. Aim 1: To establish the
independent effect of prenatal stress, and the interaction effect of prenatal diet
quality and stress, on indicators of fasting insulin resistance (HOMA-IR and Adipo-IR). Aim 2: To
conduct a randomized, controlled, cross-over study to experimentally test whether stress exposure
potentiates the glycemic and fatty acid response to a standardized meal (indicative of
postprandial insulin resistance) among pregnant women.
CANDIDATE: My background expertise is maternal nutrition in pregnancy and the
elucidation of prenatal factors that influence fetal development and child metabolic
health. My research focus has now expanded to incorporate the role of prenatal stress
and stress biology. My career goal is to develop and establish myself as an
independent, trans- disciplinary investigator addressing key questions related to a) the combined
effects of maternal diet and stress on pre-natal metabolism, and b) how prenatal biology
may be altered via maternal behavior/psychosocial state for improved fetal programming
outcomes. My short-term goals are a) to understand the prenatal biochemical effects of
maternal diet-stress interplay, and b) to advance this field of research from observational to
experimental study design.
CAREER DEVELOPMENT PLAN: My training plan is designed to allow me to acquire the professional and
technical skills necessary for a successful transition to independence as a trans-disciplinary
investigator. It includes regular meetings, structured coursework, focused tutorials,
practical training and research management under the guidance of an expert mentorship
team, led by Pathik Wadhwa (prenatal stress, DOHaD), and co-mentors Sonja Entringer (fetal metabolic programming, stress biology), Janet King (prenatal nutrition, metabolism) and Daniel Gillen
(biostatistics).
ENVIRONMENT: The UC Irvine Development, Health and Disease Research Program (DHDRP) offers myriad
resources, including an inter-disciplinary team to provide an intellectually productive
environment, research staff, office, and laboratory facilities, and experiential training in
state-of-the-art methods for studies of maternal-placental-fetal bi- ology, fetal development, and
offspring body composition, metabolic function and brain development. The UCI Institute of
Clinical and Translational Science, funded by the NIH Clinical & Translational Sciences
Award program, provides expert support to junior scientists on research design, biostatistics,
community engagement and bioassay platforms.

Public health relevance
The overall goal of this application is to provide Dr. Karen Lindsay support and protected time for an intensive, super- vised career development experience in the biomedical, developmental and nutritional sciences, leading to research independence. Based on a rigorous research question and methodology she has developed, Dr. Lindsay will conduct trans-disciplinary research to investigate the potential for maternal prenatal stress to moderate the effects of diet on gestational glucose-insulin homeostasis, an important clinical outcome for future maternal and child metabolic disease risk. This application describes her academic background, training activities, research strategy and career development plan.